The Paternal Age Effect - Enhanced Germ Cell Mutagenesis Modulated by the TRP53/APE1/MDM2 Tumor Suppressor Axis

PROJECT SUMMARY
Birth rates to older fathers increased approximately 60% since 1980, while births to younger fathers declined. Of
the nearly 4 million registered births in 2015, 11% (~440,000) were born to older fathers. Sperm from older men
have more mutations compared with young men, increasing the risk that their children will be afflicted with a
genetic disease. This increase in mutations, the paternal age effect, is increasingly significant and is directly
relevant to male reproductive aging and to child health. DNA repair declines in spermatogenic cells as mice age,
promoting an increase in mutations. Reduced levels of a base excision repair protein is causal to reduced repair
activity and increased mutagenesis in spermatogenic cells at older age. Our preliminary data indicate the
mechanisms driving increased germline mutagenesis with aging occur in meiotic pachytene spermatocytes and
involve APEX1, TRP53 and MDM2, tumor suppressors that normally function to protect against mutagenesis.
We hypothesize that chronic activation of TRP53 activates MDM2 ubiquitination of APEX1, resulting in reduced
APEX1. In Aim 1 we will test if phosphorylation of TRP53 at Ser18/23 triggers degradation of APEX1 in
pachytene spermatocytes, but not post-meiotic round spermatids, from older mice. In Aim 2. we will test if MDM2
ubiquitinates APEX1, leading to greater amounts of highly ubiquitinated APEX1 in pachytene spermatocytes,
not round spermatids, of older mice, proteasomal degradation of APEX1, and a resulting greater spontaneous
mutation frequency. In Aim 3, based upon preliminary data showing a unique distribution of APEX1, we will test
if APEX1 uniquely interacts with chromatin in meiotic cells. Methods: Defined populations of enriched specific
spermatogenic cell types will be prepared from male mice carrying targeted genetic changes in Mdm2 and Trp53
to test whether 1) these tumor suppressors dysregulate APEX1 abundance in old mice, and 2) become
chronically activated during aging resulting in decreased APEX1 abundance, decreased base excision repair,
and increased mutagenesis. The importance of proteasome degradation and MDM2 activity will be tested using
proteasome and MDM2 inhibitors. Proximity labeling will be used in vivo to identify APEX1 interacting proteins
in meiotic cells. Age-associated mutation frequency and spectra will be determined for mouse genes using
duplex sequencing. The proposed studies test a novel model in which a tumor suppressor axis (i.e. TRP53,
MDM2 and APEX1) that normally functions to safeguard genome integrity, instead compromises gamete genetic
quality by reducing APEX1 abundance and resulting in elevated mutagenesis in the unique biological context of
aging meiotic germ cells. If confirmed, this is a paradigm shift from the widely held view that the major driving
force of increased mutations in male gametes is a passive accumulation. The proposed studies will address a
fundamental biological mechanism driving increased mutagenesis that leads to the paternal age effect and may
ultimately reveal potential treatment targets to protect against genetic diseases mediated through mutagenesis
in spermatogenic cells.

Public health relevance
Project Narrative Mutations increase in male gametes as men get older, leading to older fathers being more likely to have children with a genetic disease and creating a reproductive concern for older men. Our studies elucidate involved mechanisms with a long term goal of reducing risk of genetic disease in children born to older fathers through intervention.